Molecular Biophysics of Dynamic Bacterial Nanomachines

PROJECT SUMMARY
Interdisciplinary research in the Shaffer lab centers on discovering fundamental molecular mechanisms
underpinning unilateral cargo delivery across biologically diverse membranes. Using the Helicobacter pylori cag
type IV secretion system (cag T4SS) as a robust model system, our studies focus on understanding the biology
and biophysics of intercellular DNA translocation through dynamic bacterial nanomachines assembled by
evolutionarily divergent microbes. Although H. pylori is a significant carcinogenic bacterium that stimulates the
development of infection-associated gastric malignancies, the projects outlined in this MIRA application do not
seek to study determinants of bacterial pathogenesis or aspects of microbial carcinogenesis. Rather, our studies
leverage the versatile cag T4SS nanomachine as a paradigm for understanding how a single molecular device
transports disparate microbial payload into target eukaryotic cells in a physiologically relevant context. Whereas
conjugative T4SS machineries secrete nucleoprotein complexes into recipient prokaryotes, the capacity to
translocate a bacterial oncoprotein and an expanded repertoire of fragmented nucleic acids, lipopolysaccharide
biosynthetic metabolites, and peptidoglycan substrates into human cells distinguishes the cag T4SS from other
nanomachines. Our current and future studies are uniquely poised to fill long-standing knowledge gaps in T4SS
biology to strengthen our understanding of mechanisms underscoring interbacterial and trans-kingdom cargo
delivery though diversified machineries. Studies performed by my group over the past five years yielded novel
molecular details of cag T4SS substrate translocation and led to the discovery of mechanisms underlying trans-
kingdom DNA conjugation in the context of human infection. In the next five years, we will address three major
deficiencies in our understanding of T4SS architecture, biogenesis, and function. First, despite many decades
of research, we do not understand how the cag T4SS apparatus orchestrates cargo selection and secretion, and
the mechanisms by which discordant payload is coupled to the translocation channel are unresolved. Second,
while multiple bacterial nanomachines exhibit substructure symmetry mismatch, the biological significance of
T4SS architectural asymmetry is unknown. Third, while DNA processing has been extensively investigated in
prototypical interbacterial conjugation systems, the mechanisms governing trans-kingdom DNA transfer across
donor and recipient membranes have not been elucidated in the context of human infection. Our studies will
employ powerful chemical biology, genetic, and biochemical approaches in combination with in situ cryo-electron
tomography (cryo-ET) and high-resolution fluorescence microscopy to extend our fundamental understanding of
T4SS biology and eliminate numerous ‘black boxes’ that obscure the inner workings of these dynamic machines.
Collectively, our multidisciplinary approach and collaborative efforts will continue to generate novel insights into
T4SS structural and functional diversity and will provide a mechanistic framework for the development of
innovative biotherapeutics for precision medicine.

Public health relevance
PROJECT NARRATIVE Evolutionarily divergent microbes use specialized type IV secretion system (T4SS) nanomachines to deliver diverse cargo into target cells. Using the gastric bacterium Helicobacter pylori as a model system, we propose to investigate the basic biological mechanisms governing DNA transport through the versatile T4SS apparatus. These studies will improve our fundamental understanding of conserved processes that facilitate intercellular DNA transfer from microbes to humans and will inform the development of novel therapeutic strategies.